PEDIATRIC HEART AND LUNG COMPLICATIONS OF HIV INFECTION

This project is designed to define the pathophysiology and etiology of heart and pulmonary dysfunction in pediatric HIV infection. Patients at Baylor continue to be followed up for their adult-type pulmonary function tests. Approximately 30 manuscripts are being prepared for submission to peer-review scientific journals by the investigators at 5 national centers.